Linking Mechanosensation and Cancer Progression in the Hyperglycemic Extracellular Matrix RESUBMISSION

PROJECT SUMMARY
Glycation is a chemical process whereby free sugars are added non-enzymatically to biological
macromolecules, facilitating cancer-promoting processes ranging in scope from DNA misassembly to tissue
failure. In a state of uncontrolled diabetes-induced hyperglycemia, advanced glycation end-products (AGEs)
can crosslink matrix proteins, preventing matrix turnover while increasing tissue stiffness. Risk of breast cancer
increases in patients exhibiting type 2 diabetic hyperglycemia due to a variety of factors not limited to
insulinemic inflammation, metabolic regulation by glucose signaling, and confounding behavioral or
socioeconomic factors. AGEs can also directly bind the receptor for AGEs (RAGE) to increase cytokine
secretion and promote an innate pathological inflammatory response. The extent of mechanical signaling to
epithelial cells by glycation is still unknown, though enzymatic tissue crosslinking in diabetic patients has been
targeted in clinical trials. Thus, it is of significant interest to the cancer biology field to determine the impact of
AGEs on tumor progression in a matrix-specific context, as the extent of this relationship will inform future
therapy development. The extracellular matrix (ECM) is significantly stiffer than normal tissue in many cancers,
and elevated matrix stiffness has been shown to promote metastasis; prior work in my lab has shown both in
vitro and in vivo that increased matrix crosslinking, resulting in a stiffer matrix, causes a tumor-associated
vascular phenotype. Additionally, we have recently shown that tumor burden is increased in hyperglycemic
mice, an effect which can be ablated by reversing AGE crosslinking in vivo. My data indicate that
glycation-induced stiffness increases proliferative signaling, a hallmark of cancer, and that hyperglycemic
tumors progress quicker with greater expression of mesenchymal markers than is seen in control tumors, even
when RAGE expression is silenced. Given these findings, I will use two immunocompetent models for
metastasis, and recellularized biomaterials ex vivo, to investigate the hypothesis that glycation causes specific
modifications to the tumor ECM that produce a malignant phenotype independent of secreted signaling factors.
In aim 1, diabetes-related crosslink species will be quantified and the specific contribution of the diabetic ECM
to cancer progression and metastasis will be investigated. In aim 2, the role of RAGE inflammation on cancer
progression will be explored. This work will implicate hyperglycemia in priming breast cancer for metastasis via
crosslink initiation, and drive therapeutic targeting of AGEs.

Public health relevance
PROJECT NARRATIVE Diabetes and cancer are two complex and multidimensional disease states, and exploring the direct effect that diabetes has on cancer progression has remained a challenge. It is known that patients with uncontrolled diabetes have poorer cancer outcomes, and separately it is known that the mechanical properties of cancerous tissues can contribute to cancer migration independently of chemical cues to the cell. I propose to characterize modifications to the tumor biomechanical environment made by diabetic hyperglycemia which propel metastasis with the goal of driving therapeutic discovery.